Equipment Supplement- Prolonged duration and triggered local anesthesia

Summary
Many drug delivery systems for prolonged or triggerable local anesthesia are composed of
polymers. Polymer molecular weight is a crucial parameter determining polymer function, as
well as synthesis. Gel permeation chromatography is the gold standard way to determine
molecular weight. GPC will allow us to determine exactly what the products of our syntheses
are, whether these are polymers, block polymers, polymer-drug conjugates, polymer
modification, and even nanoparticles. (All of these have been studied under the present R35.)
GPC is also useful for chemical reaction monitoring in real time to determine whether we obtain
the desired product for sustained and/or triggered release systems and to optimize the chemical
synthesis routes. GPC is also the standard way to study polymer biodegradation – an important
determinant of polymer function in vivo. GPC is a technique that we have frequently used in our
research funded by NIGMS. Access to GPC has been a serious bottleneck to our research
since there is only one at our institution and it is used for hydrophilic polymers only and is
heavily oversubscribed. Using other institutions’ GPC is costly, time consuming (travel),
suboptimal for sample stability, and impractical for real time reaction monitoring. We are
therefore applying for an administrative supplement to purchase a GPC for our lab.

Public health relevance
Narrative Drug delivery systems for prolonged or triggerable local anesthesia – the subject of our R35 award – are frequently constructed with polymers. The molecular weight of polymers is a crucial parameter in their design and performance, necessitating the use of gel permeation chromatography.